Elucidating Fundamental Principles of Dermal Pharmacokinetics via Microdialysis

PROJECT SUMMARY: This project responds to Funding Opportunity RFA-FD-20-019, “Bioequivalence of Topical Products: Elucidating Fundamental Principles of Dermal Pharmacokinetics for Microdialysis or Microperfusion Techniques (U01)”. The purpose of this proposal is to elucidate how pharmacokinetic principles and concepts (e.g., dose, fraction of drug absorbed, apparent volume of distribution, Cmax, AUCinfinity) should be applied or adapted when evaluating the rate and extent to which a topically applied compound becomes available in the dermis, at or near a site of action within the skin. The proposed work uses in vivo microdialysis to characterize dermis pharmacokinetics following the administration of drugs (i) directly in dermis via a retrodialysis/microdialysis approach (dermal infusion), and (ii) topically, from dermatological formulations. The results of these studies will permit a thorough characterization of dermis permeability (absorption), distribution, metabolism, and elimination (ADME), which will elucidate whether or not the fundamental assumptions that underlie bioequivalence assessment for systemic formulations can be applied to topical formulations. In addition, characterization of dermal ADME processes can be used to develop new strategies, concepts, and endpoints to address the issue of bioequivalence of topical dermatological drug products.

Public health relevance
PROJECT NARRATIVE: The purpose of this proposal is to elucidate how the pharmacokinetic principles and tests that were developed to assess bioavailability (BA) and bioequivalence (BE) for oral drug administrations should be applied or adapted when evaluating, with dermal microdialysis, BA and BE of topically applied compounds meant to treat skin ailments. The proposed work will assist in establishing appropriate designs and analyses leading to a more efficient development of generic products for topical dermatological products.